Lipotoxicity and Liver Inflammation

PROJECT SUMMARY
Overall Objectives of this proposal are to define mechanisms linking hepatocyte injury during lipotoxicity with
hepatic inflammation in nonalcoholic steatohepatitis (NASH). NASH is the most common pediatric liver disease
characterized by abundant circulating saturated free fatty acids (SFAs), along with hepatocyte lipotoxicity and
monocyte-derived macrophage mediated liver inflammation. Hepatocyte lipotoxicity and liver injury are, in part,
induced by SFAs and their intracellular metabolite lysophosphatidyl choline (LPC). However, cellular and
molecular mechanisms linking hepatocyte lipotoxicity to liver inflammation are not completely understood.
Emerging data implicate extracellular vesicles (EVs) released during hepatocyte lipotoxic stress in liver
inflammation. In published and preliminary experiments, we have discovered that, lipotoxic hepatocytes
release a large number of proinflammatory EVs; these EVs are enriched with the adhesion molecule integrin
β1 (ITGβ1) and promote monocytes adhesion to liver sinusoidal endothelial cells (LSECs) in vitro. We also
demonstrated that the expression of ITGβ1 ligand, vascular cell adhesion molecule (VCAM) 1, on LSECs is
increased during lipotoxicity. Based on these novel observations, we have formulated the CENTRAL
HYPOTHESIS that lipotoxic hepatocytes release ITGβ1-enriched EVs that recruit and retain monocyte in the
liver promoting inflammation. We will employ current biochemical and cell biological approaches that include
microfluidic technology, Nanoscale flow cytometry, and 89Zirconium isotopically labelled EVs visualized with
positron emission tomography (PET) scan to test this hypothesis. Our independent SPECIFIC AIMS will test
three integrated hypotheses. First, we will demonstrate that hepatocyte lipotoxicity induces an active
conformation switch of ITGβ1, enhancing its endocytic trafficking and release into EVs. Second, we will define
the mechanism of increased VCAM1 expression during lipotoxicity. We will also directly test the hypothesis
that lipotoxic hepatocyte-derived EVs mediate monocytes adhesion to LSECs, through ITGβ1-VCAM1 binding
interaction, in vitro by using microfluidic technology. Third, using a mouse model of NASH, we will test the
hypothesis that pharmacological inhibition of integrin β1 or conditional deletion of endothelial VCAM1 is
protective against liver inflammation. We will also demonstrate that adoptively-transferred lipotoxic hepatocyte-
derived EVs home to the LSECs of recipient mice through their high affinity integrin β1cargo. We have
established the requisite cell and mouse models to study lipotoxicity, integrin signaling and EV biology. This
proposal is technically and conceptually innovative, as it seeks to integrate the molecular mechanisms
underlying hepatocyte injury, integrin activation and trafficking with liver inflammation, and links hepatic
pathophysiology with nanomedicine. This research has the potential to identify new therapeutic strategies,
namely integrin and VCAM1 inhibitors, to prevent or reverse liver injury and inflammation in human NASH.

Public health relevance
PROJECT NARRATIVE The proposal examines the mechanisms of liver injury and inflammation in nonalcoholic fatty liver disease by employing models related to obesity. We propose that liver cells exposed to excess circulating toxic lipids such as saturated free fatty acids and their metabolites release abundant extracellular vesicles, which induce recruitment and retention of white blood cells into the liver and promote liver inflammation. The results of the proposal have the potential to identify new mechanisms of liver inflammation in nonalcoholic fatty liver disease (the most common pediatric liver disease), and discover new anti-inflammatory therapeutic targets for this disease.